NEURON ENOLASE IN SERUM AS PREDICTOR OF HEAD INJURY SEVERITY

Subjects which are six hours post blunt head trauma admitted to the ER will be eligible for this investigation. The study will investigate if neuron specific enolase enzyme levels are a reliable predictor of the severity of head injury.